UrogynCREST Program

PROJECT SUMMARY
Health services research (HSR) and data science are rapidly growing fields that have enormous implications
for women’s health research in pelvic floor disorders (PFDs) such as urinary incontinence, fecal incontinence,
and pelvic organ prolapse. The AUGS/Duke Urogynecology Clinical Research Educational Scientist
Training (UrogynCREST) program will prepare participants to recognize the critical role that data play in
delivering high quality health care. The program brings together expertise in health services and women’s
health research, biostatistics, decision science, and data science. It will target assistant professors in
urogynecology from across the country who seek successful careers in HSR and data science. The program
leverages the American Urogynecologic Society infrastructure to recruit participants with diverse racial and
socioeconomic backgrounds who have interest in a broad range of conditions resulting from PFDs. Three
cohorts will each spend 2 years in the program. The UrogynCREST program is an interactive, virtual, and
creative educational program with centralized activities organized at Duke and delivered by distance through
an on-line learning platform developed specifically for academia and designed to support teaching, research,
and collaboration. A diverse faculty has been assembled with expertise in data sciences and the advanced
methodology required to perform HSR and participants will obtain skills through a combination of didactic and
interactive coursework and training in the regulatory requirements and responsible conduct of research
necessary to work with healthcare databases. Nationally recognized HSR clinical mentors and peer mentors
will assist with identification of appropriate and existing database(s) to address the question and participants
will perform hands-on manipulation of data through extraction, cleaning, and analysis with biostatisticians.
Mentors will guide protocol development and each participant’s project will culminate in the publication of a a
peer-reviewed manuscript. In addition, analysis datasets, workflow and analysis codes, project metadata and
tools will be made publicly available using either the Duke Research Data Repository (RDR) or a designated
repository as specified in original data use agreements with the source. Yearly in-person meetings at the
annual American Urogynecologic Society meeting will encourage networking and the development of
partnerships among participants from various institutions, as well as interactions with the mentors and other
researchers in the field. This creative multidisciplinary, multi-institutional educational initiative is unprecedented
in the field of urogynecology and the program will shape future scientific leaders in urogynecology by
encouraging the development of clinician-scientists and provide the skills and resources for invigorating data
discovery and tools for investigations in HSR specifically addressing pelvic floor disorders.

Public health relevance
PROJECT NARRATIVE The AUGS/DUKE UrogynCREST program will teach participants how to utilize large datasets to perform research that will improve the delivery of high-quality health care for patients with pelvic floor disorders and encourage reproducible research. By providing creative educational activities that focus on research skills development and bringing together expertise in health services research, biostatistics, decision science, and data science, the program will add structure to the health data science education for assistant professor level faculty in urogynecology. Overall, the program will shape future scientific leaders in urogynecology by encouraging the development of clinician-scientists and provide the skills and mentorship for invigorating data discovery and tools for investigations in health service research specifically addressing pelvic floor disorders.